12-HETrE regulation of blood coagulation, hemostasis, and thrombosis

ABSTRACT
Platelets play an essential role in the vessel, maintaining hemostasis and normal blood flow following vascular
insult or injury under physiological conditions. While activation of the platelet is essential for adhesion and
aggregation to occur at the site of vascular injury, excessive platelet reactivity can lead to the formation of
occlusive thrombi, the predominant underlying cause of myocardial infarction and stroke. Current anti-platelet
treatments have significantly limited morbidity and mortality due to thrombosis, however they often result in an
increased risk of bleeding resulting in a need for novel targets to further decrease platelet reactivity while
exhibiting a limited increased risk for bleeding. Our lab and others have provided compelling evidence
supporting 12-lipoxygenase (12-LOX), an enzyme highly expressed in the platelet whose primary function is
thought to be to produce bioactive oxidized lipids (oxylipins) from the fatty acids embedded in the platelet
membrane, as playing an important role in the regulation of platelet activation. The role of newly studied fatty
acids in the platelet such as DGLA, DHA, and EPA has yielded strong preliminary data supporting fatty acids
and their 12-LOX oxylipins as being important for regulation of platelet function through GPCR and non-GPCR
mechanisms. Our lab has identified the first 12-LOX negative regulation pathway in the platelet whereby
formation of 12(S)-HETrE induces activation of a Gs-coupled GPCR pathway and activation of PKA resulting in
inhibition of platelet activation and clot formation in vivo while not causing an observed increase in bleeding.
We propose to investigate the underlying mechanisms by which these 12-LOX oxylipins regulate
platelet activity, clotting, and thrombosis while only minimally affecting bleeding. Therefore, we will
assess how DGLA and its oxylipin 12(S)-HETrE alters the phospho-proteome through activation of PKA,
elucidate the mechanism by which DHA and EPA regulate platelet function and clotting both ex vivo and in vivo
through their 12-LOX oxylipins while sparing hemostasis, and assess the mechanism by which the DHA 12-
LOX oxylipin 14-HpDHA can be oxidized to form a new class of maresins, Mar1-D3, in order to regulate
thrombolysis and clot resolution. Preliminary data suggests the platelet may produce a novel pool for this pro-
resolving oxylipins that could play an important role in the underlying mechanism of clot resolution in vivo.
Successful completion of this study will for the first time define the mechanism by which 12-LOX oxylipins
regulate platelet reactivity in order to both prevent clot formation and resolve pre-existing clots. Understanding
these complex signaling pathways represents a seminal advancement in our understanding of how oxylipins
like 12(S)-HETrE regulate the blood and will enable for identification of new targets on the platelet for
development of the next generation of anti-platelet therapeutics with the added benefit of limited bleeding.

Public health relevance
Blood circulation is a critical function for delivery of oxygen and nutrients and removal of waste from all cells of the body. Platelets play an essential role in the regulation of blood flow by keeping blood constituents in the vessel through hemostasis, however under pathologic conditions, this process may shift to an occlusive thrombotic event leading to full blockage of the vessel resulting in cell death, heart attack, and stroke. Lipid metabolites such as the eicosanoid 12-HETrE can regulate platelet and endothelial function and understanding this process will better enable for therapeutic treatment and prevention of thrombotic events in people at cardiovascular risk.